Role of tumor microenvironment-derived cholesterol in CD8+ T-cell exhaustion

Project Summary
Recently we discovered that cholesterol metabolically reprograms tumor-infiltrating T cells so that they
become exhausted. Our unpublished, preliminary studies showed that tumor tissues have a much higher
cholesterol content compared with normal tissues, and the PD-1high2B4high CD8+ T cells in tumor-infiltrating T
cells have significantly higher cholesterol content than PD-1med2B4med cells, which in turn have significantly
higher cholesterol content than PD-1low2B4low cells in different murine tumor models. The same was observed
in human multiple myeloma and colon tumor samples of. We also showed that the PD-1high2B4high CD8+ T cells
have significantly higher LAG-3 and TIM-3 (other T-cell exhaustion markers) expression than PD-1med2B4med
cells, and the PD-1med2B4med cells have significantly higher LAG-3 and TIM-3 expression than PD-1low2B4low
cells. Consistently, sorted PD-1high2B4high CD8+ T cells displayed much weaker cytolytic activity against target
tumor cells than PD-1med2B4med CD8+ T cells. Adding cholesterol to the culture of tumor-specific CD8+ T cells
upregulated their expression of PD-1 and other exhaustion markers and reduced their cytolytic activity.
Conversely, reducing cholesterol content in sorted PD-1high2B4high tumor-infiltrating CD8+ T cells downregulated
their expression of PD-1 and other exhaustion markers and enhanced their cytolytic activity. Based on these
novel findings, we hypothe size that the tumor and its microenvironment induce effector T -cell exhaustion by
using cholesterol to metabolically reprogram and upregulate the expression of immune inhibitory receptors and
exhaustion markers on CD8+ cells. Aim 1 will determine the mechanisms underlying cholesterol-induced CD8+
T-cell exhaustion, and Aim 2 will reprogram CD8+ T-cell metabolism and/or the tumor microenvironment to
enhance the antitumor effects of tumor-specific CD8+ T cells. Completing this project will give us in-depth
understanding of the mechanisms involved in how tumor -derived cholesterol metabolically repr ograms tumor-
infiltrating T cells so that they become exhausted. Understanding the mechanisms will allow us and others to
identify novel therapeutic targets and develop new methods to improve the efficacy of T cell- or immune
checkpoint blockade-based immunotherapy in cancer.

Public health relevance
Project Narrative We will determine 1) how cholesterol metabolically reprograms tumor-infiltrating T cells to become exhausted so they are ineffective in killing tumor cells and 2) explore new methods to counteract cholesterol’s effect and so restore T cell function in cancer patients. We hypothesize that reprogramming CD8+ T-cell metabolism and/or reducing cholesterol in the tumor’s microenvironment will effectively restore the antitumor effects of tumor-specific CD8+ T cells. Completing this project will allow us and others to identify novel therapeutic targets and develop new methods to improve the efficacy of current cancer immunotherapies.